Leadership and Administrative Core

Project Summary/Abstract – Leadership and Administrative Core
The Deep South Resource Center for Minority Aging Research (RCMAR) is designed to enhance the size and
diversity of the scientific workforce advancing the fields of minority aging and health disparities. We are a
research-based, mentoring partnership of four academic institutions, The University of Alabama at
Birmingham (UAB); The University of Alabama (UA); Morehouse School of Medicine (MSM), and Tuskegee
University (TU) working together to recruit investigators from under-represented backgrounds, provide
education in aging and health disparities research, guide career development through collaborative mentoring,
and sustain progress to successful, independent research careers. The Leadership and Administrative Core
(LAC) will provide intellectual leadership and administrative oversight for the Deep South RCMAR. The specific
aims of the LAC are to: (1) ensure the integration and coordination of all Deep South RCMAR activities, (2)
provide oversight and support for the recruitment and selection of RCMAR Scientists, (3) facilitate collaborative
mentoring and research activities with complementary programs, and (4) provide administrative oversight for
all programs. Integration and coordination of activities will be accomplished through effective interactions,
communication, and information flow externally and among investigators and Scientists across the Research
Education Component (REC), the Community Liaison and Recruitment Core (CLRC), and the Analysis Core
(AnC), as well as among the four partnering academic institutions, and with other RCMARs, the Coordinating
Center, related research centers, and the National Institute on Aging. The LAC will work closely with the other
cores and leadership of the partnering institutions to identify and recruit promising researchers from under-
represented backgrounds, establish mentorship teams tailored to each Scientist's needs, and promote
collaborations with complementary programs to support REC activities and leverage resources in support of
RCMAR Scientists. The LAC will maintain an External Advisory Committee composed of a Community
Advisory Group, a Professional Advisory Group, and a RCMAR Scientist Alumni Group, to provide feedback
ensuring that the activities of the cores are relevant both to the development of RCMAR Scientists and the
research focus of reducing health disparities among B/AA and White older adults in the Deep South. With this
renewal application, we propose to continue and enhance the activities of the LAC in serving the goals of our
RCMAR and its enduring commitment to mentoring investigators from under-represented backgrounds and to
reducing health care disparities between B/AAs and White older adults in the Deep South during the next
funding cycle.